PERU Clinical Trial Unit

PERU CTU. April 2024
PROJECT SUMMARY/ABSTRACT
The proposed renewal of the PERU Clinical Trials Unit (CTU) is built on the strengths of
the long-standing consortium between the Asociacion Civil Impacta Salud y Educacion
(IMPACTA) and the Asociacion Civil Selva Amazonica (ACSA), two nonprofit research
institutions in Peru. They have received over $110 million of investment from the U.S.
NIH during the past 19 years, to establish a comprehensive infrastructure able to support
the implementation of multiple and complex studies from diverse U.S. NIH HIV/AIDS
clinical research networks and to rapidly respond to evolving research opportunities. Two
new institutions are added in this renewal proposal, the Centro de Investigaciones
Tecnologicas, Biomedicas y Medioambientales (CITBM) and the Asociacion Civil Via
Libre. The proposed PERU CTU will be led by Dr. Jorge Sanchez (based at CITBM) and
Dr. Alberto La Rosa (based at IMPACTA), and supported by a cadre of experienced
researchers and promising junior investigators. The PERU CTU consolidated a three-
dimensional matrix organization to support the increasing number and complexity of
studies from multiple HIV/AIDS clinical trial networks, and has effectively utilized its
intellectual and structural resources to create and update innovative tools for more
efficient operations. The PERU CTU proposes to continue efficient and ethical
implementation of the clinical research agenda of the HIV Prevention Trials Network
(HPTN), HIV Vaccine Trials Network (HVTN), and AIDS Clinical Trials Group (ACTG), at
four Clinical Research Sites (CRSs) in Lima (Barranco, CITBM, San Miguel and Via
Libre), and one CRS in Iquitos (ACSA)

Public health relevance
PERU CTU April 2024 PROJECT NARRATIVE The PERU Clinical Trials Unit (CTU)´s overarching goal is to contribute to the design and implementation of the scientific agenda of the US NIH/NIAID/DAIDS research networks, across the continuum from prevention to treatment, to decrease new HIV infections, reduce HIV associated morbidity and mortality, and ultimately end the HIV epidemic. Given the high tuberculosis incidence in Peru, with high burden of resistant strains, the PERU CTU is in an advantageous position to collaborate in the design and implementation of interventions to control the TB epidemic.